Illuminating understudied druggable proteins using pan-cancer proteogenomics data

Project Summary
Proteins in the families of kinases, G protein coupled receptors, and ion channels frequently contribute
to disease pathogenesis and are good candidates for the development of therapeutics. In fact, 41% of the FDA-
approved drugs target proteins in these families. However, each of these protein families has a number of
members about which very little is known. Better understanding of these ‘dark’ members may pave the way to
new methods for treating diseases. Utilizing existing large omics datasets can be a great starting point to
generate new hypotheses on the function and phenotype association of the understudied proteins. Recently, the
NCI’s Clinical Proteomic Tumor Analysis Consortium (CPTAC) program has characterized over 1,000 primary
tumors covering 10 cancer types using multiple omics platforms. While previous large-scale omics datasets have
focused on genomic and transcriptomic data, the CPTAC data also integrate mass spectrometry (MS)-based
proteomics and phosphoproteomics. Published studies by our colleagues and us in the CPTAC consortium have
demonstrated the value of these proteogenomics datasets as a comprehensive resource for reinforcing existing
knowledge, identifying new biological insights, and generating therapeutic hypotheses. The goal of this
application is to illuminate understudied druggable proteins using CPTAC pan-cancer proteogenomics data. We
will achieve this goal by addressing two specific Aims. Aim 1 is built upon our established multi-omics data
analysis portal LinkedOmics. We will extend LinkedOmics into a knowledgebase, LinkedOmicsKB, in which
information derived from harmonized CPTAC pan-cancer proteogenomics data will be organized into gene-
centric web pages with easily browsable sections and effective visualizations. Aim 2 is based on our previous
report that protein profiling data is much more closely aligned with gene function than mRNA profiling data. We
will use CPTAC pan-cancer proteomics data to make function predictions for the understudied druggable
proteins, followed by experimental validation of selected predictions. Data, visualization, and prediction results
from both Aims will be integrated into Pharos, the knowledge portal of the Illuminating the Druggable Genome
(IDG) program, to accelerate our understanding of IDG-eligible understudied proteins.

Public health relevance
Project Narrative Despite being the targets of 41% of approved drugs, kinases, G protein coupled receptors, and ion channels each have a number of family members about which very little is known. This project aims to integrate the recently available cancer proteogenomics data from the Clinical Proteomic Tumor Analysis Consortium (CPTAC) into the characterization of the understudied proteins in these families. Successful completion of the project will generate new computational methods and resources that can be used by the Illuminating the Druggable Genome (IDG) Consortium and the broad scientific community to generate hypotheses on the function of the understudied proteins for further experimental investigation.